Dissemination and Implementation of a Videoconference Antimicrobial Stewardship Team (VAST)

Background: Antimicrobial stewardship guidelines call for a multidisciplinary team with an infectious disease
(ID) physician and ID-trained clinical pharmacist as core members. Unfortunately, there are insufficient ID-
trained specialists to staff on-site antimicrobial stewardship programs throughout VA.
Significance: This proposal is highly significant for Veterans and the goals of VA. Veterans experience many
of the risk factors associated with development of antimicrobial resistant and healthcare-associated infections.
The unprecedented effects of the novel Coronavirus disease 2019 (COVID-19) on the health of our Veterans
and on our entire healthcare system makes the demand for ID expertise even more apparent, especially in
long-term care. Also, this study directly addresses the VA MISSION ACT to improve access to care,
timeliness and quality of care, using telehealth services. Finally, this project is aligned with the priorities of
our operation partners: VA Antimicrobial Stewardship Taskforce (ASTF), the VA National Infectious Disease
Service (NIDS), VA Pharmacy Benefits Management (PBM) Services, and the Office of Rural Health.
Innovation and Impact: The design is innovative because we will systematically test and assess
implementation barriers to telehealth for antimicrobial stewardship, a novel approach that has not been
implemented in VA facilities, other than in our previous pilot study. Further, the Antibiotic Use Reports (AURs)
are an innovative adaptation of peer-comparison, an antibiotic stewardship strategy successful in outpatient
settings. This project will provide findings for a scalable model that could be deployed nationally to all
applicable VAMCs, continuing the role of VHA as a leader in implementing large-scale interventions focused
on prevention and management of ID and stewardship.
Specific Aims: Our goal is to implement a multidisciplinary videoconference antimicrobial stewardship team
(VAST) in VAMCs using SCAN-ECHO. Our central hypothesis is that feedback reports that quantify facility-
level antibiotic use will enhance the efficacy of VASTs to support antimicrobial stewardship. We propose a
Type 2 hybrid effectiveness-implementation design, comparing clinical effectiveness in sites that implement the
VAST alone (VAST-) to sites that implement the VAST augmented by facility-level Antibiotic Use Reports
(VAST+). Aims are: 1) Identify and test effective strategies for implementing the VAST; 2) Determine the
influence of the VAST overall and VAST+ on the care of Veterans with suspected infections; 3) Determine the
influence of the VAST overall and VAST+ on antibiotic use at each VAMC.
Methodology: We will randomize rural VAMCs that do not have ID-trained professionals on staff to implement
the VAST alone (VAST-) versus VAST + antibiotic use feedback (VAST+). Aim 1: We will assess modification
and adaptations at the intervention sites and by the infectious disease experts. Methods will include process
maps and semi-structured interviews to gather qualitative data about what key VAST members perceive as
facilitators, barriers and burden to VAST implementation. We will also evaluate costs of implementation. Aim 2:
We will evaluate the Veteran population served, clinical activities, and user perceptions of the VAST. We will
assess the concordance of clinical care with recommendations from evidence-based clinical practice
guidelines. VAST members’ perceptions of the quality and timeliness of care will be evaluated. Aim 3: The
primary outcome measure will be overall rates of antibiotic use. Secondary outcomes will be changes in the
rates of broad-spectrum antibiotic use, antibiotic starts, and length of antibiotic therapy.
Next steps/Implementation: Testing effective implementation of the VAST at additional VAMCs is an
important step toward augmenting antimicrobial stewardship in both acute- and long-term care settings. In
collaboration with VA clinical operation partners, outcomes from this trial will be used to roll-out an
implementation playbook to be used by other VAMCs, as well as non-VA settings.

Public health relevance
Antimicrobial-resistant and healthcare-associated pathogens are a global health threat. The goals of antimicrobial stewardship are to minimize unnecessary and inappropriate antimicrobial use as a means to combat antimicrobial resistance. Previously, we implemented a Videoconference Antimicrobial Stewardship Team (VAST) at 2 VA Medical Centers (VAMCs), using telehealth to connect clinicians at a rural VAMC to a geographically distant infectious disease expert Both VASTs successfully decreased overall antibiotic use in acute and long-term care units. This project will expand the VAST approach to other VAMCs and test the hypothesis that quarterly reports that quantify facility-level antibiotic use will enhance the efficacy of VASTs to support antimicrobial stewardship. This work will directly increase access to antimicrobial stewardship consultation at rural VA facilities, which are often underserved by infectious disease expertise.